Adapting and testing a smoking cessation intervention for transgender and gender-diverse individuals

Despite the substantial decrease in the prevalence of smoking over the past 50 years, there are persistent
and significant disparities in tobacco use among transgender and gender diverse (TGD) individuals. The
prevalence of cigarette use in TGD individuals is 45.7 - 62.3%, compared to 39.8% in cisgender individuals.1
There are also disparities in e-cigarette use among TGD people relative to cisgender adults (26.5% vs. 5.5% in
transgender and cisgender men, respectively).2 Transgender individuals may be particularly vulnerable to the
consequences of tobacco use, as hormone therapy among those who smoke increases heart disease risk,3 and
smoking may hinder recovery from gender-affirming surgeries.4
Stigma, discrimination, gender dysphoria, and other gender minority stressors contribute to tobacco use
disparities. Enacted stigma and discrimination toward TGD individuals are common (reported by over 75% of
participants in some samples5), and experiencing stigma or discrimination increases the odds of current cigarette
smoking, e-cigarette use/vaping, and dual use among TGD people.6 Gender dysphoria and gender minority
stress may also lead to and/or exacerbate disparities in anxiety and depression,7 which are major impediments
to smoking cessation8 that are more prevalent among TGD than cisgender individuals.9 Anxiety symptoms co-
occur with smoking at high rates and significantly impair cessation success.10,11 Similarly, depressed mood and
major depressive disorder, both more common among individuals who smoke than among those who do not,12–
14 are associated with reduced odds of cessation.15 Therefore, gender minority stress and high prevalence rates
of anxiety and depression render TGD individuals particularly vulnerable to smoking cessation difficulties.
A tailored smoking cessation intervention that builds cognitive behavioral skills for cessation as
well as reduces gender minority stress and associated anxiety and depression symptoms has strong
potential to mitigate tobacco use disparities among TGD individuals. We propose to adapt an existing
smoking cessation intervention (known as QUIT16) to address the unique needs of TGD people. In focus groups
with TGD individuals who use tobacco (N = up to 32) and providers (N = 8), we will explore the ways in which
gender minority stressors and associated anxiety/depression compromise cessation as well as identify content
in the current version of the QUIT intervention that does and does not meet their needs. Providers will also
comment on anticipated implementation barriers. Following the ADAPT-ITT model, the qualitative data will inform
the adaptation of the intervention. We will then test the feasibility and acceptability of the adapted intervention
(QUIT+) in a pilot RCT (N = 60); we will also assess for signals of clinically meaningful change in biologically
verified 7-day point prevalence abstinence, average number of cigarettes smoked, gender minority stress,
anxiety and depression symptoms, and distress tolerance. If deemed to be feasible and acceptable, the
intervention will be ready for a hybrid efficacy/effectiveness trial.

Public health relevance
PROJECT NARRATIVE Smoking remains the leading preventable cause of death in the United States, and there are persistent and significant disparities in tobacco use among transgender and gender diverse (TGD) individuals. Stigma, discrimination, gender dysphoria, and other gender minority stressors likely contribute to these disparities, and the increased burden of gender minority stress may also be driving higher prevalence rates of anxiety and depression, both of which are more common among TGD individuals and among those who smoke relative to comparison samples. This study will (1) explore the ways in which gender minority stressors and associated anxiety and depression compromise smoking cessation among TGD individuals, identifying elements in an existing smoking cessation intervention that need to be adjusted to meet their unique needs; (2) adapt an existing smoking cessation intervention for TGD individuals; and (3) evaluate the feasibility and acceptability of the adapted intervention in a pilot randomized controlled trial.